Low-dose RNA vaccine platform for tickborne flaviviruses

This proposal is to develop a high potency, low-dose Powassan virus (POWV) RNA vaccine candidate
using Tiba Biotech’s innovative replicon RNA delivery system. As the geographical range of ticks grows
due to climate change, the incidence of Tickborne Diseases such as POWV is expected to increase, posing a
perennial epidemic threat. There are no specific medical interventions for illness caused by POWV, which can
lead to life-threatening encephalitis, meningitis, and long-term, potentially fatal neurological complications.
Nucleic acid vaccines are an ideal approach to addressing the threat of such flaviviruses, as this technology
allows rapid response to emergent outbreaks of related strains without alteration to the manufacturing process.
Tiba’s vaccine will be innovative in two respects: 1) application of a proprietary dendrimer-based delivery system
that maximizes RNA mass content while protecting the nucleic acids from degradation and mediating cellular
uptake, 2) inclusion of highly potent replicon RNA payloads to promote single-dose efficacy through their inherent
adjuvant activity and persistent expression. In addition, the dendrimer-based formulation strategy proposed here
eliminates the need for structural lipid excipients that are used in competing RNA vaccine products, streamlining
production and enhancing safety. Two replicon POWV vaccine RNAs will be produced for evaluation in this
Phase I project, one based on an alphavirus genome, and one based on the natural flaviviral genome of POWV
itself.
The output of this study will be in vivo-validated lead vaccine candidates, which will be developed by performing
3 aims. The first Aim is to clone, synthesize, and test the two candidate POWV RNA replicon RNAs in vitro. The
second Aim is to establish the optimal nanoparticle formulations for these RNAs using Tiba’s high-capacity
modified dendrimer encapsulation platform. The formulations will be evaluated in a preliminary murine
immunogenicity trial, measuring antibody responses to select the lead candidates. In the final proposed Aim, the
best performing candidate formulations identified in Aim 2 will be advanced to a small-scale challenge study, in
which mice will be infected with POWV subcutaneously. Survival and serum viremia will be monitored to evaluate
vaccine efficacy. Evidence of protective capacity for a candidate replicon RNA POWV vaccine will serve as the
basis for a Phase II project proposal to advance this lead to further preclinical development and in-depth
immunological characterization.

Public health relevance
There are no specific medical interventions for illness caused by POWV, and infection can lead to life- threatening encephalitis, meningitis, and long-term neurological complications. As with other flaviviruses, POWV comprises an RNA genome that can undergo rapid mutation with epidemic potential. To bolster pandemic preparedness against this virus, Tiba Biotech proposes to develop a novel nucleic acid POWV vaccine candidate using our modular delivery platform, based on highly potent self-amplifying RNA payloads and a dendrimer-based delivery formulation that can be easily adapted to include sequences of other flaviviruses.